Structural studies of chromatin complexes

Project Summary/Abstract
The post-translational modification of histone proteins is now established as an important mechanism for
regulating gene expression in eukaryotic cells. However, a structural and mechanistic understanding of how
the histone modification enzymes function on their nucleosome substrate is lacking. This shortcoming limits
interpretation of the wealth of genetic, genomic and biochemical data available, and it hampers development of
new therapeutics that target the many chromatin enzymes associated with human diseases including cancer.
We are focused on addressing these deficiencies through structure determination of histone modification
enzymes bound to their physiological nucleosome substrate. We propose to determine X-ray crystal structures
of histone modification enzymes associated with human diseases in complex with the nucleosome, using
established and novel approaches to crystallize these complicated, multicomponent protein/DNA complexes.
We will complement our crystallographic efforts with use of cryoelectron microscopy for three-dimensional
structure determination of chromatin enzyme/nucleosome complexes. We also plan to use cryoelectron
microscopy to tackle structure determination of native, megadalton sized histone modification enzyme
complexes.

Public health relevance
Project Narrative In our cells, our DNA genetic information is packaged with histone proteins into chromatin. Recent studies have shown that histone proteins can be decorated by histone modification enzymes with small molecules or proteins, and these decorations regulate gene expression in normal and diseased cells. Our studies will visualize how different histone modification enzymes associated with stem cells and cancer perform their functions.